Controlled delivery of mitochondria for craniofacial bone healing

PROJECT SUMMARY
Craniofacial bone defects result from trauma or congenital deformities. Although clinical
approaches exist to fill these defects using bone grafts, poor graft take and incomplete closure of the
defect (nonunion defects) remain a major clinical challenge. The recent discovery that osteoblasts
donate their mitochondria to osteoprogenitor cells to drive osteogenic differentiation suggests that a
new therapeutic approach to harness this phenomenon and promote osteogenesis exists. In particular,
mitochondria from mesenchymal stem cells (MSCs) have been shown to provide a significant increase
in oxidative phosphorylation required for both cell proliferation and differentiation.
However, promoting sufficient levels of exogenous mitochondria transfer to osteoprogenitor
cells to observe tissue level changes remains a major obstacle because 1) there is inefficient endocytosis
of free mitochondria by cells and 2) mitochondrial “scavenging” by cells associated with the innate
immune system reduces uptake by progenitor cells. As a first step, the objective of this proposal is to
develop a biomaterial-based delivery platform that can facilitate the transfer of exogenous
mitochondria to osteoprogenitor cells to promote bone regeneration.
The central hypothesis of this work is that a strategy aimed to promote cellular uptake of
mitochondria in co-delivered MSCs as they transition to bone-forming cells, while avoiding
mitochondrial scavenging by inflammatory cells, will lead to improved bone regeneration in a calvarial
defect. Towards this goal, three specific aims are proposed: 1) Evaluate the effect of transactivator of
transcription peptide modification of exogenous mitochondria on cellular uptake and osteogenesis in
vitro; 2) Examine the effect of mitochondria release kinetics from degradable hydrogel microparticles
on uptake by co-delivered MSCs in a rat critical-sized calvarial defect model; 3) Determine the effect of
controlled mitochondria delivery on bone healing in a rat critical-sized calvarial defect model.
The proposed work is innovative because it will develop a novel biomaterials-based mitochondria
release platform to increase uptake and temporally control delivery. Results from these studies are
expected to have an important positive impact because they will lead to improved therapies for
craniofacial bone defect regeneration as well as provide insight into the role of mitochondria transfer in
bone regeneration.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because results from this study are expected to lead to improved cell-based therapies for cranial bone defects. These studies will also result in greater understanding of the role of mitochondria in bone formation. This is relevant to the NIH's mission as this research provides new methodologies that will lead directly to better treatments for many types of bone injuries.